Chromatin structure and control of gene expression in the human malaria parasite

Abstract:
Nearly half of the world's population lives in countries where malaria is endemic. Plasmodium
falciparum, the causative agent of the most severe form of human malaria, is
responsible for 95% of malaria deaths worldwide. This project's main goals are to
characterize the molecular determinants that control chromatin organization and gene
regulation in this pathogen; elucidate their importance in parasite development, virulence,
and sexual differentiation; and identify novel pathways that can be targeted to kill the
parasite. The proposed research builds upon a large body of molecular, cellular, and
genome-wide data generated in the Pl's lab that discovered how close interconnections between 3D
genome organization and transcription regulate sexual differentiation and parasite development.
Despite significant progress in the past 10 years in elucidating the role of chromatin in
transcriptional control, the mechanism underlying changes in chromatin structure and the factors
controlling these changes remain to be elucidated. The studies proposed here will examine the
proteins and long non-coding RNAs (lncRNAs) involved in the control of chromatin
structure, parasite development, virulence, and sexual differentiation. The project is
organized into three Specific Aims. Aim 1 will validate the role and essentiality of
two proteins that we previously identified as potential master regulators of male
and female sexual differentiation. Two genes encoding an AP2 transcription factor
(PfApi2AP2-FG) and a serine/threonine protein phosphatase 2A activator (PfPTPA) are
located at the boundary of two condensed chromatin super domains observed in both
early and late gametocytes. We will fully investigate the function of these proteins
during male and female gametocyte development using cellular, molecular, and genetic
approaches. Aim 2 will validate the role of two lncRNAs (lncRNAG9 and lncRNAG14) that we
previously identified as potential regulators of sexual differentiation and chromosome
reorganization during parasite development. These factors may be involved in chromosome
reorganization in gametocyte stages. We will therefore implement a set of cellular,
molecular, and genetic approaches to characterize their role in the formation and maintenance of
parasite sexual stages, as well as in the specific chromosomal reorganization we observed at
these stages. Aim 3 will systematically isolate and identify the proteins and lncRNAs
that control the structure and activity of transcriptionally silent heterochromatin
clusters in P. falciparum genome, using a novel methodology called chromatin isolation
by RNA purification (ChlRP). Once identified, factors will be validated at the
functional level using cellular and molecular experimental approaches, including genome
editing by CRlSPR-Cas9. lt is anticipated that the proposed research will offer
groundbreaking new insights into parasite-specific protein complexes and lncRNAs and their
role in chromatin structure and parasite biology, as well as many starting points for novel
directions in malaria research and therapy.

Public health relevance
Development of the malaria parasite throughout its life cycle is mostly controlled by how chromatin structure modulates gene expression. In this application, we propose to develop state-of-the-art complementary approaches to functionally characterize proteins and lncRNAs that regulate the gene expression and 3D genome architecture of the malaria agent, Plasmodium falciparum, throughout its life cycle. The proposed study will offer groundbreaking new insights into parasite biology and will also identify novel targets to kill the parasite.